Genomic Instability from Fragmented Chromosomes in Micronuclei

Project Summary/Abstract
Abnormal chromosomes are hallmark features of human diseases and genetic disorders. Cancer genome
sequencing has uncovered a complex class of localized genomic rearrangements, known as chromothripsis,
that arises from the catastrophic fragmentation of individual chromosomes. Chromothripsis is initiated by mitotic
cell division errors resulting in the formation of micronuclei, aberrant nuclear structures that transiently
encapsulate mis-segregated chromosomes outside of the nucleus. Micronuclei serve as hotspots for the
accumulation of extensive DNA double-strand breaks (DSBs) by restricting DNA damage to a confined region of
the genome. A detailed mechanistic understanding of chromothripsis, however, has been limited by inherent
challenges in monitoring micronucleated chromosomes for more than one cell cycle. We recently bypassed this
limitation by developing a platform that enables the controlled induction of chromosome-specific micronuclei in
human cells. By reconstructing the cascade of events resulting in chromothripsis, we found that damaged
micronuclear DNAs are susceptible to fragmentation upon premature chromosome condensation triggered by
mitotic entry. These fragments undergo error-prone DSB repair during the subsequent cell cycle to generate
diverse chromosomal rearrangements that are identical to those found in cancers and genomic disorders.
Moreover, we identified that short DNA fragments entrapped in the cytoplasm can activate a cell-autonomous
immune response. Despite this knowledge, we currently have a limited mechanistic understanding of the
consequences of chromosome fragmentation. For example, it remains unclear how pulverized fragments from
micronuclei re-incorporate into daughter cell genomes during mitosis and become reassembled by one or more
DSB repair mechanisms throughout interphase. Additionally, it is unknown whether chromosome fragmentation
can elicit a non-cell autonomous response. Here we outline our research program over the next five years aimed
at understanding the fate of micronucleated chromosomes across different phases of the cell cycle and its
mutagenic consequences on genome integrity. Using time-lapse light-sheet microscopy, we will interrogate the
spatiotemporal dynamics of chromosome fragmentation, movement, and reassembly during mitosis and
interphase. This will be achieved by engineering a CRISPR-based labeling strategy to visualize micronucleated
chromosomes undergoing chromothripsis in living cells. Next, we will identify how the DNA damage response
and distinct DSB repair pathways orchestrate the reassembly of chromosome fragments to shape the genomic
rearrangement landscape of mitotic errors. Lastly, we will investigate how chromosome fragments residing in
the cytoplasm can elicit inter-cellular consequences with neighboring cells in the environment, including the
lateral exchange of genetic material. Altogether, these studies aim to define fundamental principles governing
the intrinsic and extrinsic fate of micronuclei in initiating catastrophic genomic alterations. The proposed research
will fill a critical gap in our understanding of how cell cycle errors can rapidly drive somatic mutagenesis.

Public health relevance
Project Narrative Mitotic cell division errors are a major initiating source of DNA damage that can trigger diverse forms of genomic rearrangements. The proposed research will utilize multidisciplinary approaches to investigate the origins of complex genomic alterations from fragmented chromosomes entrapped within aberrant nuclear structures called micronuclei. These studies will provide critical insight into the cellular and molecular mechanisms driving a spectrum of chromosomal abnormalities that underlie a range of human diseases and disorders.